Biochemistry/Cell Biology Core

ABSTRACT -- BIOCHEMISTRY & CELL BIOLOGY MODULE
The Biochemistry & Cell Biology Module provides resources for protein, nucleic acid, and liposome purification
and analyses, intermolecular interaction characterization, large-scale tissue profiling, and cell and tissue
culturing. The module also offers instrumentation and expertise for quantitative analysis of protein expression,
phosphorylation, and lipid abundance profiles. The module arose from the needs of VRC investigators to
facilitate biochemical and cellular biological analyses among faculty who are not necessarily experts in these
fields and are specifically interested in the detection and analyses of proteins, DNA plasmids, shuttle vectors,
and small molecules. The specific aims of the Biochemistry & Cell Biology Module are to provide resources for
ultracentrifugation and centrifugation, protein and DNA quantitation, HPLC-MS and GC-MS analyses, surface
plasmon resonance (SPR) analysis, neonatal electroporation technology, cryosectioning, and tissue culture at
biosafety level 2 (BSL2).